MUST Data Science Research Hub (MUDSReH)

Overall Research Plan Project Summary. Significance. Data science hold great promise for sub-Saharan
Africa, yet research capacity and appropriate training are limited. Medical images are particularly exciting for
data science in this setting given their ability to facilitate care delivery across healthcare cadres. Efforts to
translate the knowledge gained through data science into improved clinical care can be fostered through
implementation science. Strategic multi-disciplinary, multi-institutional partnerships will be key for the
development and ultimate impact of data science for African-based solutions. Innovation. This proposal is
innovative in 1) its use of data science with medical images for advancing clinical care, and 2) integration of
data science with implementation science to promote clinical impact. Approach. The Mbarara University Data
Science Research Hub (MUDSReH) in Uganda will use multiple technologies to improve the capture of
medical images and employ key data science methods, such as machine learning and artificial intelligence, to
expand their utilization in sub-Saharan Africa. Clinical impact will be strengthened through implementation
science methods. Formal training will be available for both data science and implementation science, and
ongoing expansion of efforts will be promoted through regional summits and collaboration. The two initial
research projects—optimized posterior fundus imaging to diagnose posterior segment eye disease and mobile-
phone based cervical images to detect cancer—will involve partnerships with the College of Ophthalmologists
of Eastern, Central and Southern Africa in Kenya and the Kwame Nkrumah University of Science and
Technology in Ghana, respectively. Massachusetts Institute of Technology will provide technical support for
data management and analysis, and Massachusetts General Hospital will support the use of implementation
science and other relevant content areas for individual research projects. Each project will work with local
Ministries of Health, community-based organizations, and/or technology partners to advance the mission of
harnessing medical images for improved clinical outcomes and impact. Our specific aims are as follows:
1. To integrate all partnering academic institutions, technology companies, and non-governmental
organizations to advance data science for medical imaging. All partners will contribute to a common
infrastructure for data processing and analysis. We will establish both the administrative and technical
mechanisms for data exchange, accounting for necessary data security and quality assurance and control.
We will further create pathways for facile expansion to include additional research projects involving
medical imaging (e.g., in radiology and dermatology) at multiple African institutions.
2. To integrate implementation science with data science to advance clinical impact. All research
projects in the MUDSReH will include implementation science methodologies to ensure the developed
technology reaches the end user in practical ways that meet local needs and priorities.

Public health relevance
Medical images offer great potential for supporting clinical diagnosis and care management, particularly in low resourced settings where specialty-trained experts are lacking; however, their utility for researchers and clinicians is limited by the number of images available, insufficient linkage to relevant clinical data, limited data for proper image interpretation, and poor implementation in clinical practice. This research hub overcomes these barriers through robust Data Management and Analysis and Administrative Cores, primarily supporting projects in posterior segment eye disease and cervical cancer with multiple pilot projects in other clinical areas, as well as training in data science and implementation science. The results of this project will improve diagnostic accuracy for clinical imaging algorithms and their impact on clinical management in low resourced settings in the United States and globally.